Cellular Heterogeneity and Aging in MDS and AML

The goal of this application is to increase the efficacy of existing treatments for myelodysplastic syndrome (MDS)
and acute myeloid leukemia (AML) by identifying and characterizing RNA processing phenotypes that predict
age-related disease progression and drug resistance. Current therapies for both of these devastating diseases
are effective in only a small number of patients and predicting responses remains challenging. Improving
response rates represents a substantial unmet need for Veterans. Like many other cancers, MDS and AML are
most prevalent in aging populations. The Adaptive Oncogenesis model holds that this association is the result
of changing selective pressures acting on heterogeneous populations of cells as we age. MDS and AML are also
characterized by extensive heterogeneity. This heterogeneity is evident in the molecular profiling of cells from
individual patients, as well as in variable response to treatments across patients. Preliminary data show that
mRNA processing and regulation are also highly variable in these diseases. As changes to these processes can
play a critical role in cancer, this proposal seeks to understand how variability in mRNA processing and regulation
drives disease progression and resistance to drug treatment in MDS and AML. The proposed studies use new
sequencing methods to capture the full range of mRNA processing and regulation heterogeneity in MDS and
AML at single-cell resolution. Using primary human and MDS and AML specimens, as well as murine models of
AML, these studies will allow us to identify specific mRNA processing and regulation phenotypes that allow
malignant cells to take advantage of changes to tissue environments associated with aging and drug treatment.
Targeting the molecular mechanisms underlying these phenotypes will improve treatments and enhance the
prediction of clinical outcomes for Veterans with MDS and AML. In addition to studies using primary specimens
and animal models, this application will leverage “big data” resources to identify clinically relevant mRNA
processing and regulation signatures from that can inform the clinical management of patients. This award will
support the continued development of software tools to interpret changes in RNA processing from single-cell
sequencing data. Taken together, the proposed studies will provide important new insights into the interplay
between mRNA isoform heterogeneity, drug resistance, and aging in MDS/AML and will identify novel
therapeutic targets that can be used to improve the treatment of Veterans with these diseases.

Public health relevance
Myelodysplastic Syndrome (MDS) and Acute Myeloid Leukemia (AML) are closely related blood malignancies that are most prevalent in aging populations. Occurring typically after the age of 60, these malignancies are usually fatal. As the proportion of Veterans reaching old age is increasing, understanding the molecular mechanisms underpinning the role of aging in these diseases is critical for effective treatment. Furthermore, environmental exposure to various toxic chemicals has been linked to higher incidence of both MDS and AML, likely putting Veterans at an increased risk for both diseases. Unfortunately, treatments for MDS and AML are largely ineffective, as evidenced by a 5-year survival rate of less than 25% for AML patients. The proposed studies aim to increase the efficacy of existing treatments for myelodysplastic syndrome (MDS) and acute myeloid leukemia (AML) by identifying and characterizing RNA processing phenotypes that predict age-related disease progression and drug resistance.